New classes of small, cell permeable genome regulators to expand the age of genomic medicine

Project Summary/Abstract
Pyrrole-imidazole polyamides are a class of synthetic DNA-binding ligands that can be programmed to target
specific DNA sequences, including repetitive DNA, in the human genome. The major scientific problem this
proposal addresses is the development of two new classes of small, cell-permeable genome regulators to
extend the capabilities of these molecules. This project aims to fill the critical gap in genome targeting by
creating first-in-class small, cell-permeable genome editors that can be relationally designed to edit genomes
for a variety of downstream functions. This objective will be pursued through 3 Projects: The expected
outcomes include (1) the development of bifunctional polyamides capable of editing a tandem repeat of interest
in cell and animal models, (2) the creation of polyamides to recognize 15–20 base pair motifs occurring only
once in the human genome, and (3) the democratization of these molecules to place them in the hands of
biologists. If successful, this project could lead to novel therapeutic strategies for not only repeat expansion
disorders but genetic diseases broadly, providing new tools to researchers and advancing the field of precision
genomic medicine.

Public health relevance
Project Narrative Genetic disorders caused by repetitive DNA expansions, such as Friedreich ataxia, remain challenging to treat due to limitations in current genome-editing technologies. The proposed research aims to develop a novel class of small, cell-permeable genome editors based on pyrrole-imidazole polyamides that can be rationally designed to target and edit specific genomic regions. This innovative approach has the potential to overcome delivery and immunogenicity challenges associated with protein-based editors, potentially leading to more effective treatments for a wide range of genetic disorders and expanding the toolkit for precision medicine.